Mechanisms of Target-Specific Axon Regeneration

Project Summary
Nerve damage is a common affliction that causes sensory and/or motor deficits. Recovery involves a
regenerative process in which damaged axons within a nerve fiber must re-extend to the appropriate target
tissues, in a process known as target-specific regeneration. This process often fails in humans, leaving patients
with chronic health problems. Improving clinical outcomes requires a better understanding of how target-specific
regeneration is regulated. We know that components of the nerve support scaffold can guide axon re-extension
along simple paths. However, when axons reach nerve branch points, they require more specific guidance
mechanisms to differentiate between multiple paths and select the correct one. We have little understanding of
what environmental cues guide these decisions, and how they are appropriately interpreted by regrowing axons.
The objective of this proposal is to identify cellular and molecular mechanisms that regulate axon targeting
decisions to promote target-specific regeneration.
I have established the zebrafish vagus nerve as a model to elucidate mechanisms of target-specific axon
regeneration. Regenerating vagus axons select between five nerve branches to robustly re-innervate the correct
target tissue, although how they do so is not known. I hypothesize that two non-mutually-exclusive mechanisms
regulate target-specific regeneration: 1) chemosensation, in which a regenerating axon can interpret spatially
patterned chemical guidance cues in the environment that direct its growth; 2) fasciculation, in which a
regenerating axon can recognize undamaged axons that are innervating its intended target and use them as a
substrate for directed growth. The three aims of this proposal will comprehensively identify how growing axons
interact with their environment at the cell biological and molecular levels during target-specific regeneration. In
Aim 1, I will combine a novel single-cell chimera regeneration assay with live imaging and genetic and
pharmacological manipulations to establish a conceptual understanding of how in vivo axon-environment
interactions guide targeting decisions. In Aim 2, I will combine a novel method to label and isolate live neurons
based on their innervation target with in vivo and in vitro techniques to precisely measure how axons of each of
the five innervation target groups interact with other axons, and with chemical signals, in the environment. In Aim
3, I will combine innervation target-specific neuron isolation with RNAseq and mutant analysis for unbiased
identification of molecules that regulate target selection in each of the five innervation target groups. This study
will greatly enhance our fundamental understanding of how axons reinnervate their target tissues during
regeneration, and provide an important knowledge base to develop improved treatments for nerve damage.

Public health relevance
Project Narrative Recovery of function after nerve damage, which is a very common affliction, involves a regenerative process in which damaged axons within the nerve bundle must regrow back to their target tissues. Regeneration often fails, resulting in chronic pain and functional deficits for many patients, and therapeutic improvements are currently limited by our poor understanding of how this process is controlled. This project will use the zebrafish vagus nerve as a model to identify mechanisms that guide regrowing axons back to their target tissues during regeneration, thereby providing fundamental insights that will inform development of improved therapeutic interventions.